Salt-Sensitive Hypertension: Role of renal superoxide

About 25% of Americans have salt-sensitive hypertension. Abnormal salt retention by thick ascending limbs
(THALs) can cause this pathology. Flow of the forming urine stimulates THAL NO production by NO synthase 3
(NOS3) which inhibits NaCl reabsorption. Flow also augments O2- synthesis which stimulates Na reabsorption.
In normotensive animals, flow-stimulated NO prevents flow-induced increases in O2-. Flow increases THAL NO
via activation of TRPV4, increases in intracellular Ca (Cai), and activation of PI3 kinase, Akt and NOS3. However,
the mechanotransduction process upstream of TRPV4 is unknown. Our new data show that primary cilia and
the glycocalyx are the mechanotransducers. However, the molecular mechanisms by which primary cilia and the
glycocalyx transduce flow into TRPV4 activation and THAL NO synthesis are unknown. Estrogen protects the
glycocalyx while testosterone has no known effect. Whether there are sex differences in glycocalyx-mediated
NO synthesis is unclear. TMEM184A is a newly discovered protein that binds heparin, a glycocalyx component.
In endothelial cells, TMEM184A links the glycocalyx to TRPV4 activation and NO production. However, whether
TMEM184A plays a similar role in THALs is unknown. Dietary salt increases blood pressure (BP) in both male
and female Dahl salt-sensitive rats (SS) but more so in males. We showed that NO synthesis was lower in SS
THALs than salt-resistant (SR) tubules when rats are on normal salt, and high salt exacerbated the difference.
Although renal oxidative stress is elevated in SS THALs, the reduction in NO is not due to simple scavenging by
O2-. Oxidative stress causes glycocalyx shedding and decreases mechanotransduction of flow. However, the
roles of the glycocalyx and oxidative stress on mechanotransduction mediated by this organelle in SS THALs
have not been studied. In endothelial cells flow enhances NOS3 expression. A high-salt diet increases THAL
flow and enhances SR THAL NO synthesis by increasing NOS3 expression, but high salt does not increase
NOS3 protein in SS THALs. Whether this is due to glycocalyx shedding is unknown. Our hypothesis is that in
THALs flow-stimulated NO synthesis and NOS3 expression depends on the primary cilia displacing the
glycocalyx, which activates TMEM184A and TRPV4. Oxidative stress causes glycocalyx shedding in SS THALs,
thereby reducing flow-induced NO production, NOS3 expression and urinary Na excretion (UNaV) leading to
salt-sensitive hypertension in a sex-dependent manner. Aim 1 hypothesis: Luminal flow bends primary cilia
displacing the glycocalyx, activating TMEM184A and TRPV4, thereby stimulating NOS3 translocation and NO
synthesis by THALs from normotensive rats. Aim 2 hypothesis: THAL oxidative stress damages the glycocalyx,
blunting flow-stimulated Cai, NO synthesis and NO inhibition of NaCl reabsorption, and blocks salt-induced
increases in NOS3 protein in a sex-dependent manner. Aim 3 hypothesis: Oxidative stress-induced shedding of
the THAL glycocalyx in vivo blunts NO synthesis and UNaV, especially on high salt, causing salt-sensitive
hypertension in a sex-dependent manner. Thus, we propose a novel role for the glycocalyx in BP regulation.

Public health relevance
PROJECT NARRATIVE High blood pressure is the leading cause of loss of health world-wide. Between 25 and 30% of all Americans will develop high blood pressure in their lifetimes. About half of the people that develop high blood pressure have so-called salt-sensitive hypertension in which blood pressure rises with an increase in dietary salt. This project will study the role of a specific part of the kidney in the development of salt-sensitive hypertension in a genetic animal model of the human disease. Successful completion of the project will lead to a better understanding of the causes of salt-sensitive hypertension and may lead to new targets for drug development to treat it.